Core D: Clinical Research

Modified Project Summary/Abstract Section

The Clinical Research Core (CRC) (Core D) provides services to support researchers conducting human subjects research studies investigating the pathogenesis of HIV disease, treatment and prevention of HIV, strategies to eliminate HIV from those who are infected, and the reduction of the long-term morbidity among those with HIV infection. The Clinical Core will enable the conduct of scientifically rigorous HIV clinical and translational research through the provision of state-of-the-art research infrastructure including shared research space, laboratory services, and expert consultation in clinical research methods and study implementation. To support investigators engaged in these activities the Core will expand the use of a sophisticated clinical database, the “HIV Disease Registry” (>32,031 unique patients cared for at Emory-associated facilities, with 6,066,481 patient encounters representing over 123,972 person years of clinically relevant data). The CRC will provide access to a wide array of biological specimens and data from key populations for HIV research. The Core’s specimen repository provides access to specimens and data from populations critical to high priority research questions, including elite controllers, long-term non-progressors, people with acute HIV infection and/or acute HCV coinfection, and high-risk sero-negative men and women. The Core will foster career development of ESI and scientists new to HIV translational research. The CRC proposes the following Specific Aims: Aim 1. Facilitate the conduct of groundbreaking and community-responsive HIV clinical research via state-of-the-art research infrastructure, expansion of services to advance pediatric and adolescent research, and collaboration with the CFAR Community Liaison Council for greater harmonization of multiple community advisory boards to promote greater community engagement in all aspects of clinical research. Aim 2. Expand the use of the HIV Disease Registry to enhance international data sharing, expand data collection from Grady’s pediatric and adolescent population, and add data from Emory Healthcare. Aim 3. Provide access to data-linked biological specimens from key populations in HIV research; renew the focus on children, adolescents, and young adults, while continuing to strengthen the participation of women; and expand our biobank for emerging research. Aim 4. Foster career development for the next generation of HIV researchers through Core services and programs and through collaboration with the Developmental Core.